Bioengineering Cornea with Autologous Stem Cells

This Multi-PI project combines the efforts of two research groups with different areas of expertise to address the
long-term goal of developing bioengineered corneal stroma and endothelial tissues to provide therapy for
individuals with corneal blindness. These tissues will be bioengineered from adult stem cells, which can be
obtained from the individuals to be treated as autologous or from allogeneic cell storage since the stem cells are
immunosuppressive. Over the past 5 years we have demonstrated that organization of these cells into tissues
can be guided by scaffolds constructed of native extracellular matrix proteins, fabricated using a biomimetic,
surface-induced assembly process. The Du Lab at the University of Pittsburgh will obtain stem cells from limbal
stroma of donated human corneas. Their extensive work with these corneal stromal stem cells (CSSC) shows
that they differentiate to stromal keratocytes and to corneal endothelial cells, tissues responsible for most corneal
opacity. We have demonstrated that CSSC can be obtained from biopsy samples, presenting the opportunity to
generate patient-specific, autologous bioengineered tissues. The Feinberg Lab at Carnegie Melon University
has developed novel approach of assembling native extracellular matrix proteins to produce tissue-like
scaffolding with defined 3-D architecture. Aim 1 will build on our previous work, which has showed that we can
engineer spatial and biochemical cues provided by the scaffolding to generate stroma-like tissue from CSSCs
that can be stacked to form multilamellar 3-D tissue similar to that of the corneal stroma. Bioengineered stroma
produced in the proposed experiments will be subjected to biomechanical loading to simulate cornea
development and further improve mechanical and optical properties. Function of the bioengineered stroma in
lamellar keratoplasty will be evaluated in an in vivo rabbit model. Aim 2 will build on our work differentiating
CSSC into endothelial cells and growing these on engineered basement membrane protein scaffolds to form
polygonal monolayers that express genes typical of corneal endothelium. Previously, we demonstrated the ability
to create the equivalent of Descemet's membrane to bioengineer an entire sheet of endothelium suitable for
lamellar keratoplasty, but we also developed an alternative approach to engineer small patches of endothelium
and deliver these via simple injection. Bioengineered endothelium produced in the proposed studies will use
our newly developed “shrink-wrapping” technology to create microscale patches of corneal endothelium that can
be injected into the anterior chamber for injury-free engraftment. Functionality of the constructs will be
demonstrated in rabbit models in vivo, focused on boosting cell-density to improve pump function as an
alternative to lamellar keratoplasty for endothelial disease. This project will build on the innovative experimental
approaches we developed during the first 5 years of this project. Importantly, tissues developed and validated in
vivo during this proposed study hold the potential of being advanced into clinically relevant studies to provide a
novel therapeutic approach to the age-old problem of corneal blindness.

Public health relevance
PROJECT NARRATIVE Millions of individuals are blind due to corneal opacity but their vision cannot be restored with a corneal transplant due to their body's rejection of transplanted tissue or because of the inability to obtain donor tissue. Previously we developed bioengineered corneal tissues that use a patient's own adult stem cells, so that barriers to restoring corneal vision due to shortage of donor tissue or rejection can be greatly reduced. The goal of this current work is to further improve the mechanical and optical properties of these tissues and to continue translation of this technology toward the clinic by validating restoration of vision using an in vivo model.